Deciphering the Role of mRNA Nuclear Localization in Circadian Rhythms

Abstract
Circadian clocks align our physiological functions with Earth's day-night cycles through rhythmic gene
expression. While the genetic framework of circadian clocks has been well characterized, the mechanisms
responsible for the crucial long-time delays within circadian feedback loops, necessary for establishing a 24-hour
periodicity, remain poorly understood. While the importance of clock protein degradation in generating temporal
delays was recognized over two decades ago, the roles of subcellular localization and RNA metabolism
regulation in contributing to these delays have yet to be explored. To address this critical gap, our lab has recently
adapted single-molecule RNA-FISH and a machine-learning-based analysis to visualize and quantify individual
clock mRNAs in Drosophila clock neurons. Using this technique, we made an unexpected discovery that the
mRNAs of timeless (tim), a core clock gene, are localized to not only the cytoplasm but also to the nucleus,
specifically near the nuclear speckles. These nuclear speckles are RNP (ribonucleoprotein) condensates
enriched for splicing factors, essential for mRNA processing. To identify the sequences responsible for the
nuclear localization of tim mRNAs, we examined the splicing of tim introns in the clock neurons of Drosophila.
Our studies have revealed an intriguing pattern in the splicing of tim introns: intron 5 is consistently retained in
almost all nuclear tim mRNAs, unlike other tim introns, which are spliced at the gene locus concurrently with
transcription. This distinctive retention of intron 5 suggests it is spliced post-transcriptionally, which could lead to
a delay in the export of tim mRNA from the nucleus to the cytoplasm, resulting in a delayed accumulation of TIM
protein. Further, a novel transgenic fly line with tim intron 5 deletion resulted in shortened ~22-h circadian
rhythms, suggesting that regulated post-transcriptional splicing of this intron is critical for introducing delays in
the circadian feedback loops, which is essential for ~24-h circadian rhythms. Next, we found that clock neuron
specific knockdown of Precursor RNA Processing 3 (Prp3) protein, a U4/U6.U5 tri-snRNP splicing factor, caused
a majority of tim mRNAs to be localized to the nucleus due to the failure to splice out tim intron 5 specifically,
leading to very low levels of TIM protein and completely arrhythmic behavior. This study provides the first
evidence, within any model system, that the post-transcriptional splicing of a specific intron within a core clock
gene plays a critical role in generating essential temporal delays in ~24-h circadian clocks. In this grant, we aim
to: i) decipher the sequences that are required and sufficient for the nuclear localization of tim mRNAs, and ii)
determine the molecular mechanism by which Prp proteins regulate the post-transcriptional splicing of tim intron
5 and affect circadian rhythms. Our experiments will reveal novel mechanisms governing post-transcriptional
splicing and mRNA nuclear localization, elucidating their precise role in regulating circadian rhythms and
providing new insights into gene regulation broadly in development and disease.

Public health relevance
Project Narrative Circadian clocks align our physiological functions with Earth's day-night cycles by orchestrating rhythmic expression of many genes, including those related to sleep, metabolism, and immunity. Our recent discovery reveals a crucial, yet unexplored, role for post-transcriptional splicing and mRNA nuclear localization in the generation of ~24-hour circadian rhythms. Understanding the molecular mechanisms of post-transcriptional splicing is crucial not only for unraveling the complexities of circadian rhythms, but could also pave the way for novel therapeutic strategies targeting RNA processing in various diseases. .